The Impact of Environmental Exposures on Sarcoidosis Incidence and Mortality

PROJECT ABSTRACT
Sarcoidosis, a multiorgan disease with an uncertain etiology and variable clinical outcomes, is potentially
influenced by environmental exposures, such as organic fuel burning or inorganic dust. The higher incidence
and prevalence of sarcoidosis among veterans than in civilians provides a rationale to examine the role of
service-related toxic exposures in the natural history of the disease. Such studies are consistent with the goals
of the recently approved PACT Act, which recognizes sarcoidosis as a service-related illness and calls for studies
of service-related exposures as risk factors for lung disease. The Veteran's Health Administration (VHA), the
largest integrated healthcare system in the U.S., obtains comprehensive longitudinal data on millions of veterans,
including their unique history of service-related toxic exposures. This wealth of data enables the exploration of
these relationships with high precision. My central hypothesis is that service-related toxic exposures affect the
incidence of sarcoidosis and all-cause mortality. I propose two specific aims: (1) to determine in a nested case-
control study whether service-related exposures increase sarcoidosis incidence risk among veterans and (2) to
identify predictors of all-cause mortality among veterans with sarcoidosis using a time-dependent Cox
proportional hazards model and two other machine learning models; in two subaims, I will determine whether
individual clinical features predict all-cause mortality and whether incorporating the service-related exposures
into the models will improve this prediction. This study will reveal the effects of toxic exposures on sarcoidosis
incidence, develop predictive models for all-cause mortality, and stratify veterans into risk subgroups—which will
improve longitudinal care and guide efforts to identify new sarcoidosis phenotypes. The findings will lay the
foundation for a Career Development Award proposal focusing on real-world, evidence-based management
strategies for sarcoidosis.

Public health relevance
PROJECT NARRATIVE Sarcoidosis is a complex disease that affects multiple organs and causes inflammation. Consistent with the goals of the recently approved PACT Act, the proposed studies will investigate the impact of service-related toxic exposures on the development and outcomes of sarcoidosis among veterans, using data from the Veteran's Health Administration. The findings will reveal whether toxic exposures increase the risk for sarcoidosis and identify factors that predict overall mortality, this knowledge will help improve healthcare for veterans and could lead to new management strategies.